Georgia CaRes

Augusta University has been home to Georgia's only NCI Community Oncology Research Program
Minority/Underserved Community Site (NCORP M/U Community Site) since 2014. In partnership with DeKalb
Medical Center, Morehouse School of Medicine, University Blood and Cancer Center in Athens, Phoebe
Putney Medical Center in Albany, Augusta Oncology Associates in Augusta, and St. Dominic-Jackson
Memorial Hospital in Jackson, Mississippi, the Georgia CaRes NCORP M/U Site has enrolled 408 patients to
NCI clinical trials, 47% of which are African American and other minorities. The main goals of this application
are to sustain and grow our NCORP Community Site, focusing on improving patient outcomes and reducing
health disparities in M/U populations throughout the State of Georgia and beyond. Georgia has some of the
nation's worst cancer disparities. The cancer experience for African Americans in Georgia varies widely from
that of Caucasians and is especially evident in the disproportionate and astounding mortality rates from
several common cancers (e.g., colorectal and breast cancers). Our original program was aptly named Georgia
CaRes (Georgia Cancer Research) and represents our shared commitment to cancer research, including
studies in cancer control, cancer prevention, and cancer care delivery, as well as clinical trials from NCI's
National Clinical Trials Network (NCTN). The renewal of Georgia CaRes will allow us to continue to serve
large regions of the state with high concentrations of minority and medically underserved populations. We will
accomplish this through the following Specific Aims: 1) Georgia CaRes will facilitate participation and
enrollment of patients and healthcare providers into cancer control, prevention, and cancer care delivery
research (CCDR) studies developed by NCI's Research Bases and in human research trials of the National
Clinical Trials Network (NCTN); 2) Georgia CaRes will support and strengthen NCORP goals by improving
the scope of our activities as an NCORP M/U Community Site; and 3) Georgia CaRes will increase
collaboration across our NCORP M/U Community network and with the Research Bases. Renewal of Georgia
CaRes will have a significant and far-reaching impact on the health of minority and underserved populations
within the State of Georgia and beyond.

Public health relevance
The State of Georgia experiences significant cancer incidence and mortality disparities within its minority and underserved communities. Our Georgia CaRes NCI Community Oncology Research Program (NCORP) Minority/Underserved Site addresses these disparities by focusing on providing clinical trials, cancer control and prevention trials, and cancer care delivery research to Georgia's minority and underserved communities (rural, inner city). Renewal of Georgia CaRes will greatly impact the public health (especially with respect to cancer) of minority and underserved communities within the State of Georgia and beyond.